A highly opioid responsive VTA projection to the dorsal endopiriform nucleus.

SUMMARY
The dorsal endopiriform nucleus (DEn) is a highly conserved structure found in mammalian brains that is
developmentally related to the claustrum and has been linked to the claustrum's role as the “seat of
consciousness”. The DEn is connected to more limbic regions than the claustrum, has a very dense projection
to infralimbic cortex, and receives strong inputs from sensory cortices especially olfactory and gustatory regions.
While the DEn's role in behavior remains largely unknown beyond contributing to the generation of seizure
activity, it has long been known to have extremely high levels of mu, delta, and kappa opioid receptor (MOR,
DOR, and KOR) protein and mRNA. In preliminary studies we discovered a mostly non-dopaminergic ventral
tegmental area (VTA) projection to the DEn; these neurons show a significantly stronger hyperpolarization in
response to the MOR agonist DAMGO than any other VTA projection we have investigated. This is an exciting
find because opioid reward, including intra-VTA opioid reward, is dopamine independent in opioid naïve animals.
Thus, this non-dopaminergic, MOR sensitive projection may contribute to this opioid reward. Since the DEn
receives inputs from a variety of sensory cortices, this is also a potential site of direct interaction between
reinforcement encoding from the VTA and sensory cue information. Here we propose to anatomically map the
VTA innervation of the DEn, characterize the VTA  DEn synaptic connectivity including its MOR sensitivity,
and test whether selective modulation of this circuit connection produces reward or promotes learning or salience
signaling. Together these studies will lay the groundwork for understanding a previously unstudied but highly
opioid sensitive output of the VTA to an opioid receptor enriched brain region situated to integrate information
from across cerebral cortex.

Public health relevance
NARRATIVE The dorsal endopiriform nucleus (DEn) is a long, thin subcortical brain region that is highly connected with the limbic circuit and considered by some to be the limbic component of the claustrum, however its function remains largely unknown. We have found a non-dopaminergic projection from the ventral tegmental area (VTA) to the DEn that is strongly inhibited by mu opioid receptor activation. Here we propose to anatomically and functionally characterize the neural connection from the VTA to the DEn and investigate the contribution of this connection to behavior.